Core H - Basic Science Core

PROJECT SUMMARY/ABSTRACT
CORE H: BASIC SCIENCE
The mission of the Providence-Boston CFAR Basic Sciences Core (BSC) is to build and support collaborative
research between clinical, behavioral, translational, and basic science investigators with a focus on NIH
HIV/AIDS high priority areas including Ending the HIV Epidemic, HIV immunology, HIV cure, and addressing
HIV-associated complications, especially aimed at benefiting minority populations. The restructuring of the BSC
in the last cycle has been very successful, taking advantage of the partnership between Lifespan/Brown and
Boston University/Boston Medical Center and these institutions’ strengths in basic and translational sciences.
This partnership has significantly enhanced the basic science expertise of the CFAR, as well as its user pool
and basic science institutional support. In the next five years, the BSC will provide standard and innovative
services to HIV/AIDS researchers based on evolving needs as determined through regular surveys, and
significantly expand the Core user pool through outreach and education. The BSC will enhance its technical
capacity by sharing expertise and centralizing labor-intensive tasks. Importantly, the BSC will take an active role
in identifying, consulting, mentoring and training investigators, particularly new and early stage investigators
across the CFAR, as well as established investigators who are new to, or wish to expand into, HIV research, or
lack the technical expertise or lab resources for their studies. The BSC will promote collaborative basic and
translational research through three Specific Aims: (1) Support HIV research by providing essential lab assays
and expertise; (2) Develop and support innovative services and new collaborations; and (3) Provide training and
mentorship to local, national and international investigators with a wide range of HIV experience. Overall, the
Core will provide CFAR users conventional as well as innovative services and a scientific infrastructure dedicated
to multidisciplinary basic science and translational HIV/AIDS research, and the guidance to strengthen capacity
for lab-associated HIV/AIDS research training and education around the world.